Mechanistic clinical trial evaluating the role of the metabotropic glutamate receptor subtype 5 (mGluR5) in the antidepressant mechanism of Cognitive Behavioral Therapy for Insomnia (CBT-I)

More than 80% of adults with depression endorse one or more symptoms of insomnia, such as high sleep
latency (difficulty falling asleep). When comorbid insomnia is not addressed, it results in worsened depression
severity, a doubled probability of relapse and increased risk of suicide. Conversely, cognitive behavioral
therapy for insomnia (CBT-I), a treatment solely aimed improving sleep, reduces depression with rates similar
to conventional antidepressants. Although this efficacy reflects the interrelationship between sleep and
depression, CBT-I’s antidepressant mechanism of action is currently unknown. One potential mechanistic
pathway is through the metabotropic glutamate receptor subtype 5 (mGluR5), due to its strong association with
both depression and sleep. Preclinical studies repeatedly implicate mGluR5 in the pathophysiology of
depression. Correspondingly, mGluR5 antagonists and negative allosteric modulators induce a dose-
dependent antidepressant effect. In humans, we and others have shown altered mGluR5 density in major
depressive disorder (MDD) in vivo and postmortem. We have also shown that ketamine reduces mGluR5
density, and these reductions are correlated with its antidepressant efficacy. In terms of sleep, four different
studies across rodents and humans have shown that global increases in brain mGluR5 density are induced by
one night of sleep deprivation. Conversely, lower mGluR5 density in humans is correlated with less subjective
sleepiness and reduced markers of sleep need. In our own pilot data in two different cohorts and using three
modalities (positron emission tomography [PET], self-report surveys and polysomnography), we have found
that lower mGluR5 density is significantly associated with better sleep, including lower sleep latency.
Taken together, we hypothesize that a reduction in mGluR5 is the common pathway between sleep and
depression improvement. We will test this hypothesis in 42 adults with MDD and a range of sleep latencies.
We focus on reduction of sleep latency as a readout of improved sleep given that it is easily quantifiable,
significantly improved by CBT-I, and correlated with depressive symptoms. mGluR5 density (quantified by
PET) and sleep latency (quantified by polysomnography) will be assessed before and after nine weeks of a
validated, online CBT-I program developed by MPI Dr. Ritterband. We hypothesize that (1) CBT-I will result in
a significant reduction of mGluR5 density, (2) this reduction will be correlated with reduction in sleep latency
(improved sleep) and (3) CBT-I will be most effective in those with high pretreatment mGluR5, establishing a
personalized marker of treatment efficacy. In exploratory analyses, we will examine other measures of sleep
and all brain regions. Upon hypothesis validation, this study would be the first to show that a lifestyle-based
intervention can alter mGluR5 density. As mGluR5 has been implicated in many disorders, and
medications targeting mGluR5 have generally not been viable in humans due to significant side effects, a
sleep-based mechanism of altering mGluR5 would have multiple therapeutic implications beyond depression.

Public health relevance
The results of this mechanistic study will provide first evidence for the role of the metabotropic glutamate receptor subtype 5 (mGluR5) in the antidepressant mechanism of cognitive behavioral therapy for insomnia (CBT-I). Further, by demonstrating that mGluR5 can be modulated in humans with CBT-I, we will have validated a medication-free, easily disseminated technique that can improve depression and other diseases associated with mGluR5.